Pilot Project Program

ABSTRACT: PILOT PROJECT PROGRAM
The mission of CEED is to improve human health by performing translational research using emerging
science, engineering, and technology to determine how the total environment, the genome and the epigenome
interact to modulate the risk of disease. The Pilot Project Program (PPP) is one of the Center’s most valuable
mechanisms for achieving this mission. Funded by CEED and supplemented by institutional commitment from
partner academic units, the Program fuels new initiatives, collaborations, recruitment and scientific training of
the faculty (especially junior faculty), and is critical to formulating responses to emerging environmental health
needs of the State and Nation. The PPP catalyzes development of careers in environmental health sciences
through interdisciplinary collaborations and funding of innovative and high risk/high return projects that might
be difficult to initiate using tradition mechanisms. CEED Pilot Projects are the primary driver of research
involving non-traditional academic partnerships representing new directions for the Center or in areas of
emerging science and technology.